Discovering Care Coordination Practice Patterns in the EMR: Interpretation and Impact on Patient Outcomes

Healthcare expenditures in the United States reached $3.5 trillion in 2017, up 4.6 percent from 2016. It has
been recognized that prolonged length of stay (LOS) and unplanned readmission are two of the primary
causes of higher healthcare costs. Determining which factors are associated with prolonged LOS and
unplanned readmission will provide valuable knowledge about how to reduce costs and improve care delivery.
The Agency for Healthcare Research and Quality (AHRQ) has recognized that care fragmentation under a fee-
for-service system can lead to various problems, including poor harmonization of services and unnecessary
testing and procedures, all of which have the potential to extend LOS and unplanned readmissions. Effective
care coordination, has been proposed to resolve many of these problems, and is a priority of the National
Quality Strategy, which is led by AHRQ.
Yet, there are numerous challenges to measuring the effectiveness of care coordination. In particular, there is
a lack of a clear relationship with a patient’s outcome (e.g., prolonged LOS or unplanned readmission).
Electronic medical record (EMR)-based care coordination measures have been highlighted by AHRQ for three
potential advantages: i) minimal data collection burden, ii) rich clinical context and iii) longitudinal patient
observation. However, current EMR-based measures focus on an assessment of EMR systems (e.g.,
meaningful use) and compare effectiveness of care at a coarse-grained level (e.g., the relation between
meaningful use of an EMR system and reduction in LOS or unplanned readmission rates). Unfortunately, such
measures neglect the specific drivers (e.g., variations of interactions between healthcare professionals) of
variability in LOS and unplanned readmission rates. In this project, we will develop an EMR-based framework
to characterize care coordination at a fine-grained level, which accounts for the interaction network between
two or more healthcare professionals (e.g., doctors, nurses, social workers, care managers, and supporting
staff) involved in a patient’s care - and measure its impact on LOS and unplanned readmission.
To achieve the goal, we will design i) data mining algorithms to automatically learn care coordination patterns
and analyze LOS and unplanned readmission from the EMRs of ~2.3 million patients at a large academic
medical center with a long history of EMR use; ii) hypothesis-driven approaches to quantify the relationship
between a learned pattern and LOS and unplanned readmission, where a patient’s demographics (e.g., age,
race and sex) will be considered as confounding variables; and iii) an interpretation process to translate the
inferred patterns into actionable criteria for HCOs. This research is notable because methods created in the
project can be served as a scientific basis to automatically i) learn care coordination patterns across a wild
range of healthcare services and health conditions; and ii) measure the effectiveness of these patterns via their
relationships with various patient outcomes (e.g., LOS and unplanned readmission).

Public health relevance
Project Narrative It has been suggested that care coordination can resolve many current care related challenges such as poor harmonization of services, as well as unnecessary tests and procedures, all of which have the potential to extend length of stay and unplanned readmissions. Yet a major challenge that stands in the way of realizing the goals of care coordination on a large scale is there is a lack of methodologies to efficiently assess the effectiveness (eg, relationship with LOS or unplanned readmission) of care coordination with respect to a large range of healthcare services and health conditions. The overarching goal of this project is to learn care coordination patterns through the data stored in electronic medical record systems, assess their influence on care effectiveness (in the form of LOS and readmission), and evaluate the extent to which they are ready for adoption by healthcare organizations through comprehensive surveys and interviews with knowledgeable healthcare experts.